Hijacking cancer driver to activate cell death by chemically induced proximity

Abstract
Personalized targeted cancer therapy, while initially effective, leads to resistance and disease progression in
>50% of patients in as rapidly as few months after initiating therapy. These therapies directly inhibit the
catalytic and/or ligand-induced functions of the cancer driver, leading to resistance via mutational escape or
epigenetic/transcriptional bypass. To address mutational escape, recent therapeutic approaches leverage
Chemically induced Proximity (CiP): bifunctional molecules that recruit two proteins into proximity for an
emergent therapeutic effect. However, current CiP-based therapies are limited to degradation, which suffers
from similar feedback mechanisms of resistance as direct inhibition of the cancer driver. Then, we recognized
that 45% of all cancer genes are direct transcriptional regulators. Therefore, this proposal outlines a novel CiP-
enabled therapeutic paradigm to hijack cancer drivers to amplify a therapeutic transcriptional program to
directly kill cancer cells.
Specifically, the goal of this proposal is to hijack the estrogen receptor in breast cancer to drive overexpression
of pro-apoptotic factors to induce cancer cell death. First, I will systematically define the most potent pro-
apoptotic factors for transcriptional upregulation induced cell death across multiple estrogen receptor positive
breast cancer cell lines. Second, I will identify and validate transcription factors that regulate these pro-
apoptotic factors by integrating bioinformatic analysis with a high throughput transactivator inducible
recruitment screen. Finally, I will demonstrate that estrogen receptor in breast cancer can be hijacked for
targeted transcriptional upregulation by recruiting it to an endogenously tagged transcription factor regulator of
potent pro-apoptotic factors and to a targeted dCas9. Together, I will identify and demonstrate that estrogen
receptor can be inducibly recruited by CiP to a transcription factor regulator of pro-apoptotic factors to induce
breast cancer cell death.
The successful completion of the aims described will establish not only a novel therapeutic approach for
estrogen receptor positive breast cancer but also a generalizable therapeutic paradigm across multiple cancer
types with transactivating cancer drivers. Furthermore, I will identify robust candidates for subsequent
therapeutic heterobifunctional molecule development. The proposal presented also reflects my training goals of
becoming an interdisciplinary physician-scientist bridging chemical biology tools and epigenetic gene
regulation to address critical problems and needs in cancer biology and therapy.

Public health relevance
Project Narrative Existing targeted cancer therapies rely on inhibiting or degrading cancer drivers, leading to therapy resistance and subsequent disease progression. While therapeutic approaches that leverage chemically induced proximity have shown promise in overcoming mutational escape, they have largely been limited to degradation approaches, with similar resistance risks as direct inhibitors via epigenetic/transcriptional feedback. In this proposal, I aim to hijack the estrogen receptor by chemically induced proximity to transactivate a pro-apoptotic transcriptional program in breast cancers, to develop and demonstrate a novel targeted gain-of-function cancer therapeutic paradigm.